Microbiota-based probiotics to treat inborn errors in metabolism

Project Summary/Abstract
The human gut is a metabolic organ where anaerobic microbial pathways run at high capacity, expanding the
biochemical landscape of the human body. Exploiting members of the gut microbiota and the metabolic
pathways they encode represents an exciting new strategy to treat genetically encoded biochemical defects in
humans such as Phenylketonuria. There are three reasons why identifying new microbiota probiotics should
be a priority: 1) Gut microbes represent an important yet untapped resource for new metabolic pathways that
influence human biochemistry. 2) Microbiota pathways are present in healthy individuals, and their metabolic
end products are unlikely to be toxic to humans. 3) Native, non-genetically modified strains are likely to have a
straightforward regulatory pathway for use in humans. While this proposal is focused on identifying microbes
and pathways to reduce blood phenylalanine levels to treat phenylketonuria, our long-term goal is to lay the
foundation for an entirely new approach to treat inborn errors in metabolism: controlling metabolic circuits via
the gut microbiota. Our proposal is organized into the following two aims: In Aim 1, we will use gene cluster
searches, transcriptomics, genetics, and metabolomics to identify and characterize anaerobic pathways for
phenylalanine metabolism by gut bacteria. In Aim 2, we will assess the ability of microbial pathways to reduce
plasma Phe levels in a gnotobiotic mouse model of phenylketonuria (PKU). Our results will not only provide
new insights into how the microbiome expands the biochemical landscape of the host but will also lay the
groundwork for a new approach to treating inborn errors in metabolism.

Public health relevance
Public Health Relevance Statement: The human gastrointestinal tract is home to a large number of functionally diverse microbes that influence the chemicals circulating in our body. Inborn errors in metabolism are human genetic diseases where toxic chemicals accumulate to high levels in the blood. In this proposal, we will identify beneficial microbes isolated from the guts of healthy humans and develop approaches to use these microbes as probiotics to treat inborn errors in metabolism.